Variation in early motor function in autism, cerebellar injury and normal twins

Project Summary
Autism spectrum disorder (ASD) is one of the most common and highly inherited of all developmental disorders,
with heritability exceeding 0.80. Although remarkable advances in genetics have identified rare de novo
mutations in select brain genes, by definition, none of these relate to the pronounced heritability of autism
relevant to the vast proportion of cases in the population. Given that heritability has been shown to be a function
of additive genetic risk, inferring an impractically large number of genetic targets for intervention, an important
strategy is to identify convergent mechanisms of polygenic risk factors by elucidating intermediate phenotypes
(i.e., endophenotypes) through which they exert their causal influence. Our group has identified two such
candidates that appear highly contributory but not sufficient for ASD: (i) the social behavioral phenotype indexed
by quantitative (subclinical) autistic traits in parents (QAT-p); and (ii) variation in social visual engagement (SVE),
an eye-tracking measure based on viewing of dynamic social scenes. Both can be ascertained in the first year
of life using rapid acquisition methods of less than 20 minutes. Our team’s prior work strongly supports a
developmental model in which autism arises from joint additive genetic effects of these and other
neurodevelopmental liabilities, suggesting that targeting a discrete group of early-contributing liabilities before
autism develops offers the greatest opportunity for high-impact, personalized intervention for children at risk for
common, polygenic forms of ASD.
The primary objective of this research program is to validate wearable-sensor methodology (bilateral, wrist-worn
accelerometers) for quantifying two additional endophenotypes: hyperactivity (HYP, as an early marker of
liability to Attention Deficit Hyperactivity Disorder, which is strongly comorbid with autism) and
impairment in motor coordination (MOT). We will examine HYP and MOT in three distinct samples. Aim I
will study 120 pairs of infant twins first assessed at 6 months of age and then followed at ages 18 and 36 months
to evaluate early associations between HYP, MOT, QAT, and SVE, as well as their heritability and ability to
predict quantitative variation in autistic traits among the twins. Aim II will study a cohort of 50 toddlers diagnosed
with idiopathic ASD to determine whether novel sensor-based metrics of HYP and MOT show differences
between the twins and children with ASD. Aim III will study a legacy cohort of 120 infants at elevated risk for
autism due to prematurity and/or cerebellar injury, in whom we will explore relationships between cerebellar
structure and function in the first year of life and a) sensor-based indices of HYP and MOT, b) quantitative autistic
traits, and c) performance-based indices of motor ability at age three years. This project is expected to yield a
rich, comprehensive understanding of motor endophenotypes in infants and children and their contributions to
autism, with the eventual goal of providing a launching point for future screening and early intervention studies
in high-risk children.

Public health relevance
Project Narrative Previous research strongly suggests that most autistic syndromes in the population arise from permutations and combinations of a discrete group of independent neurodevelopmental liabilities, some specific to autism, some not. Interventions which target these contributing neurodevelopmental liabilities in an individual before autism develops may offer the greatest opportunity for high-impact, personalized early intervention. In this program, we will validate novel, sensor-based methods for first-year-of-life measurement of two major liabilities: hyperactivity and impairment in motor coordination, which account for over a third of recurrence risk for autism in families, but which are not yet reliably measurable in infancy in a manner that can be implemented in general population screening or in developmental research.